Novel Nanomedicine-Based Therapeutic Approach For Treatment of Cancer Cachexia

Project Summary
Cachexia is a debilitating metabolic disorder that affects 50% of all cancer patients. Numerous clinical trials
confirmed that the wasting of skeletal muscle mass is the hallmark of cachexia. During the course of the R37
parent grant, the research team developed the first messenger RNA (mRNA) therapy for metastatic ovarian
cancer and cachexia-induced muscle wasting. It is based on lipid nanoparticles (LNPs) that deliver follistatin
mRNA predominantly to cancer cells following intraperitoneal administration. The secreted follistatin protein,
endogenously synthesized from delivered mRNA, efficiently reduces elevated activin A levels associated with
aggressive ovarian cancer and ameliorates cachexia in this condition. By altering the cancer cell phenotype,
mRNA treatment prevents malignant ascites, delays cancer progression, induces the formation of solid tumors,
and preserves muscle mass in cancer-bearing mice by inhibiting negative regulators of muscle mass. Finally,
the mRNA therapy provides synergistic effects in combination with cisplatin, increasing the survival of mice and
counteracting muscle atrophy induced by chemotherapy and cancer-associated cachexia.
Recent literature demonstrates that activin A increases the metastatic potential and decreases survival in head
and neck cancers. Therefore, the research team will assess the efficacy of the developed mRNA therapy to
reduce metastasis and preserve muscle mass in a new preclinical model of metastatic head-and-neck carcinoma
that readily metastasizes to the lung and exhibits all the hallmark features of human cachexia.
Whilst the loss of lean muscle mass is the hallmark of cancer cachexia, treatment for cachectic patients must
also comprise therapeutic strategies that target systemic inflammation and stimulate appetite to ensure adequate
energy and protein consumption. The research team will also develop the appetite-stimulatory therapy based on
the above-discussed LNPs loaded with mRNA coding for both ghrelin and its specific O-acyltransferase (GOAT,
required for full ghrelin activation). Previous reports suggest that ghrelin, a gut-secreted hormone, is a potential
therapeutic agent for the treatment of appetite and weight loss in patients with cachexia. The proposed study will
evaluate the efficacy of ghrelin mRNA-based therapy to improve food intake, body composition, and survival in
a murine pancreatic cancer model of cachexia. Finally, anti-inflammatory therapy for the treatment of systemic
inflammation in cancer cachexia will be developed using anti-inflammatory drug-loaded nanoparticles that
accumulate efficiently at the site of inflammation following systemic administration. The research team has
already constructed polymeric nanoparticles equipped with peptides as a targeting moiety for vascular cell
adhesion molecule 1 (VCAM1) that is overexpressed in endothelial cells during inflammatory insults, with
particularly high expression in hypothalamic centers regulating appetite. The efficacy of these IRAK4 inhibitor-
loaded nanoparticles to reduce hypothalamic inflammation and increase food intake will be evaluated in the
above-discussed murine pancreatic cancer model.

Public health relevance
PROJECT NARRATIVE Cachexia is a debilitating metabolic disorder characterized by an involuntary loss of lean body mass, systemic inflammation, and negative protein and energy balance. It is the primary cause of death for up to 30% of cancer patients and there are currently no effective therapies to manage cachexia. The proposed project will provide novel nanomedicine-based therapeutic strategies that stimulate appetite and attenuate cachexia-associated muscle wasting and systemic inflammation in cancer patients.